Ionically Conductive Polymeric Biomaterials and Grafts for Nerve Regeneration

Peripheral nerve injuries (PNI) affect millions of people in the US, and PNI with large gaps require surgical repair.
Although biological and synthetic grafts are widely used to repair PNI with large gaps, they both can suffer from
suboptimal clinical outcomes. Autografts are the gold standard treatment but are limited by availability and defect
repair size, while synthetic grafts have poor biodegradability, strength, bioactivity, and functionality. Thus, the
long-term objective of this proposal is to engineer grafts with enhanced large-gap nerve regeneration capabilities.
Physical and chemical stimulation can enhance nerve regeneration responses, thus, incorporating these
modalities into engineered grafts may address some current treatment limitations. Electrical stimulation (ES) can
enhance nerve conduction, neurotrophin release, and functional recovery of nerve crush injuries, but these
benefits have not been established for large-gap PNI. Chemical stimulation using 4-aminopyridine (4-AP; a
potassium channel blocker) appears similar to ES in its effects on neurons and can enhance crush PNI repair,
yet may act synergistically with ES. Implementing these physical and chemical cues for effective large-gap PNI
repair will require surgical insertion of an electrically conductive scaffold with appropriate mechanical strength,
degradation, conductivity, and pore properties. This proposal aims to deliver 4-AP and ES via novel,
biodegradable, ionically conducting (IC) chitosan scaffolds and hybrid-engineered nerve allografts to repair large-
gap nerve defects. We found that IC scaffolds with ES+4-AP treatment in large-gap nerve defects increased
neurotrophin release, myelination, compound action potential, and gastrocnemius muscle weight beyond ES or
4-AP alone. Increased blood vessel growth and reduced fiber capsule thickness surrounding scaffolds with
ES+4-AP treatment indicate improved biocompatibility and regeneration. Significantly higher levels of genes for
TrkA, TrkB, and TrkC receptors and NGF, BDNF, NT3, and CD31 were found for ES+4AP treatment important
for nerve regeneration. Therefore, it was hypothesized that IC scaffolds combined with chemical and electrical
cues will modulate cell-material interactions to enhance axon regeneration rate and functional recovery
comparable to autografts. This will be tested with three Specific Aims: 1) Characterize ionically conducting (IC)
scaffolds with variations in drug release rate, conductivity, and biodegradation; 2) Assess human and rat
Schwann cell responses to IC scaffolds with 4-AP and/or ES in vitro to model in vivo responses and future
interventions; and 3) Test long-term safety and efficacy of engineered scaffolds and allografts with 4-AP +/- ES
in a critical-sized sciatic nerve defect. Engineered repair of large-gap PNI using bioactive electrical and chemical
cues will broadly impact the field. These studies will bridge the knowledge gap between the complex ES-
mediated cell-material interaction microenvironment and poorly studied underlying regeneration pathways.
These findings may improve the treatment of nerve defects, and inform exploratory work on regenerative
strategies for innervation in other musculoskeletal tissues.

Public health relevance
Project Narrative Every year, over half a million Americans suffer from large-gap peripheral nerve injuries that require surgical treatments with neural grafts or engineered graft substitutes, but these treatments suffer from limited availability and efficacy. Our objective is to address these issues by developing novel ionically conductive biodegradable scaffolds for reliable electrical and chemical stimulation to enhance the regeneration of large-gap nerve injuries. By bridging the knowledge gap between how chemical and electrical stimulation influence cell-material interactions and poorly studied nerve regeneration pathways, this project has the potential to significantly enhance large-gap nerve regeneration and functional recovery, ultimately benefitting patients suffering from peripheral nerve injuries.